Core 4: Dissemination & Policy

PROJECT SUMMARY: Dissemination & Policy Core
Since CHERISH was established in 2015, economic research to inform policymakers and the public regarding
treatments for substance use disorder, HCV, and HIV has only increased in importance. Substance use
disorder has claimed the attention of mass media and policy makers, but large gaps remain in the translation
and use of evidence. Although economic evidence can help bridge this gap by addressing costs, tradeoffs, and
sustainability of best practices, research must address stakeholders’ priorities to have policy and public health
impact. Findings must be communicated effectively to the right audience, in the right format, at the right time.
To meet these needs, the CHERISH Dissemination & Policy Core uses the tools of dissemination science to
assess, facilitate, and build researchers’ and stakeholders’ capacities to exchange knowledge. In this renewal,
the Core will expand its role as a knowledge broker and translation capacity builder connecting researchers
and stakeholders, and we will directly assist research teams. Our affiliation with the Leonard Davis Institute of
Health Economics at the University of Pennsylvania brings deep expertise in translation and dissemination of
health policy research – including engaging stakeholders and researchers in settings that build expertise in
dissemination science theory and practice, promote information exchange, and leverage clinical experience in
treatment of SUD, HCV, and HIV. The overall aim of CHERISH (Center for Health Economics of Treatment
Interventions for Substance Use Disorder, HCV, and HIV) is to develop and disseminate economic evidence
that informs substance use disorder policy and HCV and HIV care of people who use substances. In this
renewal period we will expand our focus to outcome and implementation research conducted at the individual,
system, and community-levels with the following specific aims: 1) to engage stakeholders and health
economics researchers in information exchange and translate health economic research results addressing
substance use disorder treatment policy and HCV and HIV care for people who use substances, and 2) to build
the dissemination science knowledge base in substance use disorder policy and HCV and HIV care by
developing and implementing training on best practices for stakeholder engagement and communication of
relevant economic methodologies, and by conducting relevant dissemination science research. We will
translate research results for target policy audiences, with a focus on state and local policymakers and
influencers. Our dissemination science activities will assist research teams, incorporating findings from our
stakeholder needs assessment and face-to-face engagement with decision makers and their advisors including
members of our Policy Advisory Board. We will develop, pilot, and implement a curriculum for substance use
health economics and health services researchers to improve knowledge translation capacity. After the
curriculum is established, we will host workshops at national meetings to introduce and refine the curriculum.